Single cell multi-omics of iPSC-derived brain organoids from patients with opioid use disorder: synthetic opioids as molecular probes

Project Summary/Abstract
Synthetic opioid-involved overdose deaths have increased sharply. Fentanyl is driving many of those overdose
deaths. However, oxycodone is one of the most prescribed opioid medications in the US. Current in vitro assays
and in vivo models designed to study the pathophysiology of opioid use disorder (OUD) and to discover potential
therapeutic targets are useful, but there is a need for additional model systems. Our preliminary data and serval
preclinical study using single-cell sequencing have revealed that each opioid agent might have unique molecular
profiles and mechanisms of action. Those findings highlight the need for additional models to evaluate drug
action in the brain at the single-cell level. Our research team combines expertise in addiction medicine,
pharmacogenomics, and bioinformatics, expertise required to develop a computational and experimental
framework to integrate gene expression and chromatin accessibility in induced pluripotent stem cell (iPSC)-
derived brain organoids. The goal of the proposed study is to provide novel mechanistic insight into drug action
at single-cell resolution. Our research strategy involves the use of single-cell sequencing technology and
iPSC-derived 3D brain organoids to identify molecular signatures for OUD using two commonly prescribed
synthetic opioids: oxycodone and fentanyl as molecular probes. Aim 1, we will define molecular characteristics
of response to synthetic opioids: oxycodone and fentanyl exposure of iPSC-derived forebrain organoids from
both OUD patients and healthy controls at the single-cell level. Aim 2, we propose to reconstruct transcriptional
regulons in different cell types in the brain organoids by applying novel network biology approaches to prioritize
potential candidates, to detect meaningful biological information embedded in the sea of Big Data and to uncover
novel regulatory mechanisms that explain the properties of biological phenotypes. These approaches could help
to develop mechanistic hypothesis for experimental validation. Aim 3, we will study genes and pathways
identified from Aim 1 and Aim 2 with regard to their potential use as novel drug targets for OUD treatment or
prevention, by pursuing functional genomic studies using appropriate iPS-derived CNS cell types and brain
organoids Our findings will enhance the general understanding of drug mechanism(s) of action and the
underlying pathophysiology responsible for opioid addiction in a drug-dependent fashion, thus opening new
avenues to discover novel therapeutic targets for the treatment of OUD. In summary, this proposal is based on
extensive preliminary data, and decades of experience in using drugs as “molecular probes” for underlying
genomic and other omic mechanisms. As a result, the proposed studies have significant implications for
molecular mechanisms leading to understanding of the pathophysiology of OUD as well as the discovery of novel
therapeutic agents for OUD treatment and/or prevention. If successful, our research approaches could be
generalizable to other opioids and to other substance use disorders.

Public health relevance
Project Narrative Current in vitro assays and in vivo models designed to study the pathophysiology of opioid use disorder (OUD) and to discover potential therapeutic targets are useful, but there is a need for additional model systems. Our research strategy involves the use of induced pluripotent stem cell (iPSC)-derived 3D brain organoids and single-cell sequencing technology to identify molecular signatures for OUD using two commonly prescribed synthetic opioids: oxycodone and fentanyl as molecular probes. This approach will make it possible to advance our understanding of both drug action and of disease pathophysiology at the single-cell level.